THE SYNAPTIC TYPE LANDSCAPE OF ALZHEIMER'S DISEASE VISUALIZED BY MULTIPLEX EXPANSION SYNAPTIC NANOSCOPY

THE SYNAPTIC TYPE LANDSCAPE OF ALZHEIMER'S DISEASE VISUALIZED BY MULTIPLEX EXPANSION
SYNAPTIC NANOSCOPY
Abstract
Alzheimer's disease (AD) is the most prevalent neurodegenerative disorder, with high morbidity and mortality
and high costs toward patient care and management, posing a major global public health issue. In addition, the
link between AD and neuroinflammation suggests that this burden may significantly increase in the years
following the COVID-19 pandemic. AD is characterized by memory loss, cognitive decline, and devastating
neurodegeneration associated with synaptic dysfunction and loss. Genome-Wide Association Studies implicate
diverse molecular pathways for human AD disease, but the way that these genetic results relate to synaptic
pathology is unclear. In situ proteomic profiling of synapses across the brain is critical to shed light on potential
mechanisms and therapies. Unfortunately, conventional bulk and single-cell biochemical and sequencing assays
lack spatial resolution for fine-scale synaptic analysis as well as the isolation of discrete synaptic types that may
be differentially affected in AD. Although super-resolution fluorescence imaging methods can offer sufficient
spatial resolution, multicolor imaging is limited to ~4 protein targets due to spectral overlap, which cannot reveal
the convoluted pictures of synaptic pathology in AD. Built upon our innovative molecular imaging platform
supported by the parent DP2, here we propose a nanoscale synapse imaging method that will determine high-
dimensional protein location and protein-protein interactions at synapse in both normal and pathological states
with commercially available reagents, for both clinical AD samples as well as in mouse models of
amyloidogenesis. The outcome of our work will lead to a broadly useful in situ proteomic tool for quantification
of neuronal synapse types available to diverse neuropathology laboratories and will foster a better understanding
of the complexity of molecular mechanisms of AD for development of novel therapeutics.

Public health relevance
Narrative Alzheimer's disease is the most common neurodegenerative disorder with 5 million US cases that are projected to rise to ~14 million by 2050. Yet, we know little about the molecular mechanism of this devastating synaptic disease to identify unique phenotypic signatures that correlate with developing AD. The overarching goal of this proposal is to generate an in situ proteomic profile of cognitive decline at the synapse level, to understand mechanisms of synapse loss during the onset of AD and relate genetic predisposition to changes in synapse populations defined by multiplex expansion synaptic nanoscopy (MExSyN).